Clinical Resources Core

Although some improvement has been made since the Oklahoma Shared Clinical and Translational Resources
(OSCTR) initiation, Oklahoma remains consistently in or near the bottom 10% of states for the overall health of
its population. Oklahoma’s residents disproportionately suffer from chronic health problems, such as obesity,
diabetes, cardiovascular disease, and arthritis/autoimmunity. Oklahomans have a life expectancy of 4 years
shorter than the average US citizen, while American Indians have a life expectancy of more than 7 years
shorter than other groups within the US. With high percentages of rural (34%) and tribal (16%) populations,
Oklahoma has unique challenges and opportunities to implement clinical and translational research (CTR)
projects and dissemination and implementation research to improve health and disease outcomes. The Clinical
Resources (ClinRes) Core of the OSCTR has built a centralized system to support human subjects research
focused on these issues. The Core provides clinical research facilities and staff to assist with participant
recruitment and regulatory approvals, a CAP-certified Biorepository that has allowed the OSCTR to adopt or
establish registries, repositories, and cohorts to assist investigators in obtaining and utilizing high-quality
samples to support their research efforts, and infrastructure for accessing de-identified patient data to support
clinical research projects. These efforts have allowed the Core to support the careers of multiple CTR
investigators, including researchers who are members of the under-represented minority communities in the
state. The ClinRes Core will continue to provide this invaluable access to sample collections while supporting
the establishment and growth of new repositories focusing on the health issues of greatest concern to our
populations, including cancer, diabetes, and arthritis. The ClinRes core will continue to work with the
Community Engagement and Outreach (CEO) Core to build on the strong relationships developed with smaller
community organizations across the state during the COVID-19 pandemic. Together, these collaborations
enhance the overall opportunities of our CTR investigators to expand clinical study and trial access to residents
throughout the state to help increase participant diversity and address our rural and minority health disparities.
The ClinRes Core will continue to provide junior investigators with essential assistance with institutional IRB
applications, protocols, data safety monitoring boards, and other regulatory requirements and will work with the
Administrative Core to make access to resources and information more accessible to investigators, clinicians,
clinical research staff, and participants through the Gateway to Oklahoma portal. With the CEO Tribal
Engagement Unit, we will assist investigators in working with the Indian Health Service and tribal IRBs,
ensuring the protection of both individual human subjects and tribal community populations. Finally, we will
continue developing and supporting resources to grow our clinical research informatics capacity to facilitate
local and national research efforts.